The HMP Next Gen digital health platform: accelerating research implementation, amplifying public health impact

PROJECT SUMMARY/ABSTRACT
Comprehensive evidence-based, multi-component interventions are needed to address risk reduction and self-
management across the HIV care continuum. Interventions targeting traditional HIV risk behaviors without
addressing contextual issues like access to care, mental health, and stigma are likely to exacerbate inequities
in HIV incidence and perpetuate ongoing health disparities. Digital Health Interventions (DHIs) are well-suited
to address these challenges given the ubiquity of highly personal mobile technology, however, DHI creators
face major barriers when creating, managing, disseminating, and scaling evidence-based tailored
interventions. Recent advances in data science present a salient opportunity to create resources that
accelerate and improve the process of developing DHIs and empower intervention developers to better
address diverse real-world needs and deliver health-promoting activities across at-risk populations. Our team
has been at the forefront of designing stand-alone DHIs that have shown promise for impacting distinct HIV
continuum outcomes. Our DHI platform, HealthMpowerment (HMP), was built upon years of prior human-
centered design and rigorous clinical trials research and has demonstrated significant reductions in HIV
transmission risk behaviors, increased engagement in HIV care and decreases in perceived HIV stigma.
However, to be most impactful, HMP requires optimization and modernization to further improve its reach and
to better meet the needs of the research community and potential end-users. This Phase II project proposes to
build on the prior funded work and develop a unified study management platform to aid researchers to
efficiently develop and deploy behavior change interventions and effectively manage participants throughout
the duration of their trial engagement. We have assembled a team with expertise in digital user experience,
software development, and behavioral science with a strong focus on intervention research related to HIV
prevention. Leveraging this expertise, our proposal aims to refine and evaluate HMP Next Gen, a
comprehensive, evidence-based digital health solution poised to expedite culturally meaningful research to
promote health equity. In Aim 1, using human centered design, and working iteratively with expert
stakeholders, we will streamline and expedite platform deployment by automating the process through the
development of researcher facing tools. This includes transition to a cloud-based server, and development of a
robust content management system and self-service portal for research project deployment. In Aim 2, we will
modernize and expand capabilities of HMP to facilitate study implementation, including participant
management, administration workflow and the ability to capture and respond to real-time analytics. In Aim 3,
we will evaluate the impact of newly created tools on study deployment and implementation. If successful,
HMP Next Gen will reduce research costs and management burden, by expediting study start-up and
implementation with a goal of improving health outcomes and reducing inequities.

Public health relevance
PROJECT NARRATIVE Recent advances in data science present a salient opportunity to create resources that accelerate and improve the process of developing digital health interventions and empower intervention developers to better address diverse real-world needs and deliver health-promoting activities across at-risk populations. We propose to refine and evaluate HMP Next Gen, a comprehensive, evidence-based digital health solution poised to expedite culturally meaningful research to promote health equity. If successful, HMP Next Gen will reduce research costs and management burden, by expediting study start-up and implementation.